Implementing a tech platform for training & consumer access to nanny agency sourced caregivers; a nascent elder companion care workforce

Abstract
The number of Americans ages 65 and older is projected to increase from 58 million in 2022 to 82 million by
2050. Finding elder care services to help elders age in place successfully has been a common stressor among
family caregivers. Elder care workforce shortage, stress, and burnout combined are significant factors in
exacerbating the elder care crisis. Despite start-ups emerging in the elder care space, a lack of appropriately
trained and qualified caregivers can lead to unsafe and unsustainable conditions for elders. Home healthcare
agencies, that traditionally place nurse assistants, home health nurses, and elder companions, often operate
with manual processes, cumbersome insurance and payment structures, and tend to focus more heavily on the
medical aspects of aging. Elder care companionship typically provides psychosocial support, assistance with
activities of daily living, age and condition appropriate engaging activities, home-related task assistance, and
has enormous potential to serve millions of elders who seek to age in place. In prior start-up work within the
nanny industry, the PI has identified parallels between developmentally appropriate, family assistant-type
nanny work and that of elder companionship. Although some nannies currently take on elder companion
caregiver (ECC) work, hundreds of thousands of nannies and in-home child caregivers may also be potentially
interested this role. Therefore qualified, agency vetted nannies who transition to ECC work are a nascent,
promising, and capable workforce that may significantly mitigate the elder care crisis. The aims of the Phase 1
SBIR NIA proposed project are to (1) conduct customer discovery with nanny agency owners who seek to grow
or develop ECC services in their businesses while confirming nannies on their roster seek this work, (2) identify
nanny agency design partners to implement an ECC specific scheduling, booking, and marketing platform for
agencies, and (3) develop, implement, and test a succinct ECC training that specifically transitions nannies to
the ECC role. In Phase II we will test the efficacy of our elder care technology and training by comparing
outcomes of those who receive care from nannies-to-ECCs versus those who do not. A significant market
opportunity exists for the estimated 200,000 nannies practicing in the U.S. who are nanny agency affiliated,
have established expertise in in-home care, and receive ECC training to assist a robust aging population in
need of their services.

Public health relevance
Narrative The U.S. elder care crisis is largely fueled by lack of a qualified, capable, and available care workforce. Novel solutions include looking to other care verticals, such as the in-home childcare space, for workers with transferrable skillsets that are well positioned to meet elder care needs. Our BookLilli care technology seeks to cultivate, train, and deploy a nanny-agency vetted child caregiver workforce to become elder companion caregivers to mitigate the elder care crisis.